Neural and molecular control of subordinate social status in a cichlid fish

PROJECT SUMMARY/ABSTRACT
Social stability for many species is maintained via social hierarchies, wherein displaying subordinate behavior to
higher ranking individuals is key. A subordinate social rank influences the brain and behavior by altering neural
circuitry and the production and signaling of neuromodulators, such as steroid hormones and neurotransmitters.
For example, androgens tend to be negatively correlated with a subordinate social rank, while the neural
expression of the serotonin 1A (5-HT1A) receptor is positively associated with subordinate behavior. Although
clear relationships have been established between a subordinate social status, the brain, and behavior, the
molecular and neural mechanisms regulating these changes are not known. A major challenge in elucidating
these mechanisms is that social rank is often tied to both physiological and behavioral traits, making it difficult to
distinguish the effects of neuromodulators (e.g., androgens and serotonin) on individual traits associated with
social subordination. Thus, the use of novel model organisms, in which distinct traits of subordinate social status
can be studied in isolation, is necessary to enhance our understanding of the neuroendocrine regulation of
subordination. The proposed work will use state-of-the-art sequencing and genome editing technologies to
identify genes and cell types in the brain that govern subordinate social status in the African cichlid fish
Astatotilapia burtoni. A. burtoni is a highly social species in which males display subordinate or dominant
behavior based on social status. Recent work showed that androgen receptor (AR) mutant males generated via
CRISPR/Cas9 gene editing do not exhibit distinct traits of dominant social rank. For example, ARα mutants do
not perform dominant behaviors (mating or aggression), whereas ARβ mutants lack bright coloration and show
reduced testes growth, making these fish an excellent tool for taxing the molecular and neural systems controlling
distinct aspects of subordinate social status. In Specific Aim 1, I will identify cell types and their genetic signatures
in the hypothalamus of dominant WT males and subordinate WT and AR mutant males using single-nucleus
RNA sequencing. In Specific Aim 2, I will determine the role of androgens in regulating subordinate social status
by measuring physiological and behavioral traits of social rank in subordinate AR mutants. Finally, in Specific
Aim 3, I will generate novel mutant A. burtoni lacking the 5-HT1Aβ receptor using CRISPR/Cas9 gene editing to
assess the role of serotoninergic signaling in governing social subordination. Based on preliminary data showing
that AR and AR mutants display distinct physiological responses to social suppression, I predict these mutants
will have cell type-specific gene expression patterns that mirror different aspects of subordination. Moreover,
given the known relationship between androgen and serotoninergic signaling, I expect to observe contrasting
deficits in physiological and behavioral traits of subordination in AR and 5-HT1Aβ mutants that reveal the roles of
these systems in controlling subordinate social status. Collectively, these studies will yield important insights into
the basic neural and molecular mechanisms that regulate subordination in social animals, including humans.

Public health relevance
PROJECT NARRATIVE Social hierarchies, which are comprised of lower-ranking subordinate individuals and higher-ranking dominant individuals, are essential for maintaining stability in humans and other species; however, the neural and molecular mechanisms that regulate a subordinate social rank and its associated behaviors are unclear. The proposed research will use state-of-the-art tools in gene sequencing and genome editing to identify the genes and cell types in the brain that govern subordinate social status and assess the roles of androgens and serotonin in regulating subordinate behavior in an African cichlid fish Astatotilapia burtoni. Given that all vertebrates have androgens, serotonin, and similar genes that regulate behavior, this work will elucidate basic biobehavioral and genetic mechanisms underlying subordination that can be further explored in other animals, including humans.